O-Specific Polysaccharide Responses and Cholera

PROJECT SUMMARY (See instructions):
Cholera is a severe dehydrating illness of humans. It is endemic in over 50 countries and causes 3 to 5
million cases a year, resulting in approximately 100,000 deaths. Currently available cholera vaccines are
poorly immunogenic in children under the age of 5 years, and often do not induce robust long-term memory
responses in immunologically na"fve populations. Antibodies targeting O-specific polysaccharide (OSP) are
associated with protection against cholera. We here propose to extend our highly productive ongoing R37
international program that is defining OSP-specific immune responses in humans with cholera, including
how OSP-specific antibodies protect. Such knowledge would be high impact and would directly inform
cholera control efforts, including advancement of next generation cholera vaccines. In Aim #1, we will
continue to define mechanisms of protection against V. cholerae afforded by OSP-specific responses using
human isogenic OSP-specific monoclonal antibodies and human enteroid models. In Aim #2, we will define
single cell and population responses at the mucosal surface in mucosal tissue samples obtained through
endoscopic biopsy of cholera patients using single-nuclei sequencing (snRNA-seq) with T cell receptor
(TCR) and B cell receptor (BCR) sequencing. In Aim #3, we will (a) define the OSP-specific response in
intestinal tissue and luminal contents of patients recovering from cholera in Bangladesh, (b) deeply
interrogate peripheral blood antigen-specific and functional immune responses using a system serologybased
approach, and correlate these responses to responses directly assessed at the mucosal surface [in
(3a)], and (c) assess the validity of whether such peripheral markers predict protection against cholera in
our ongoing household contact study in Bangladesh. This extension builds upon our fully-approved and
ongoing human, animal and bench-top studies, protocols and samplings, including at the International
Centre for Diarrhoeal Disease Research-Bangladesh (icddr.b); no new additions are proposed.
One Page Project Summary/Abstract of the Research Plan for the R37 Extension
This is an R37 extension request that proposes to continue to advance our understanding of antibodies
targeting O-specific polysaccharide (OSP) of Vibrio cholerae, the cause of cholera. This extension builds upon
our current proposal and does not involve expansion of efforts beyond the approved Scope of Work/Efforts. Our
current scope focuses on understanding OSP-specific responses during cholera and includes vertebrae and
human subjects work, and our extension continues these ongoing efforts (no new animal or human subject
efforts other than period extension). Our current project period has been quite successful; we are meeting all of
our current Specific Aims and our efforts have resulted in 22 Open Access peer-reviewed publications in the
current period-to-date (2020-2023, to date). In our proposed extension to R37106878, we propose
continuation of three specific aims. In Aim #1, we will continue to define mechanisms of protection against V.
cholerae afforded by OSP-specific responses; this will include assessing isogenic clones of OSP-specific
human lgA, lgM and lgG in our human intestinal organoid model, assessing impact on motility, toxin delivery,
and bacterial genomic gene expression; and using a complement deficient mouse model to directly assess if
vibriocidal activity of OSP-specific antibodies is required for mediating protection at mucosal surfaces. In Aim
#2, we propose to define single cell and population responses at the mucosal surface in mucosal tissue
samples obtained through endoscopic biopsy of cholera patients using single-nuclei sequencing (snRNA-seq)
with T cell receptor (TCR) and B cell receptor (BCR) sequencing, building upon our previous bulk-cell
transcriptional and proteomic analyses. In Aim #3, we propose to (a) define the OSP-specific response in
intestinal tissue and luminal contents of patients recovering from cholera in Bangladesh, (b) deeply interrogate
peripheral blood antigen-specific and functional immune responses using a system serology-based approach
and correlate these responses to immune responses directly assessed at the mucosal surface in cholera
patients in Bangladesh [in (a)]. Once we identify peripheral profiles associated with high level and durable
mucosal OSP-specific responses, we will (c) assess the validity of whether such peripheral markers predict
protection against cholera in our ongoing household contact study in Bangladesh. This extension builds upon
our fully-approved and ongoing studies, protocols and samplings, including at the International Centre for
Diarrhoeal Disease Research-Bangladesh (icddr.b); no new additions are requested.
SPECIFIC AIM #1.A: Assess impact of human monoclonal J.gQ OSP-specific antibodies in a human intestinal
organoid model.
SPECIFIC AIM #1.B: Assess impact of isogenic human monoclonal OSP-specific 19.M and lgA antibodies in the
human enteroid model.
SPECIFIC AIM #1.C: Use complement-deficient mice to assess whether protection afforded by anti-OSP
antibodies mechanistically involves vibriocidal functional activity at the intestinal surface.
SPECIFIC AIM #2.A: Define duodenal tissue cell states during acute and convalescent V. cholerae infection via
application of single-nuclei sequencing (snRNA-seq) with T cell receptor (TCR) and B cell receptor (BCR)
sequencing.
SPECIFIC AIM #2.B: Identify immune cell signatures in blood that track with V. cholerae infection via
application of single-cell RNA-seq (scRNA-seq) with CITE-seq (cellular indexing of transcriptomes and
epitopes) with TCR and BCR sequencing.
SPECIFIC AIM #3.A: Define OSP-specific responses in intestinal tissue and luminal contents of patients
recovering from cholera in Bangladesh.
SPECIFIC AIM #3.B: Deeply interrogate peripheral blood OSP-specific and other-specific and functional
immune responses using a system serology-based approach and correlate these responses to the directly
assessed immune responses at the mucosal surface in cholera patients in Bangladesh.
SPECIFIC AIM #3.C: Assess the validity of whether peripheral markers identified in Aim 3.B predict protection
against cholera in our ongoing household contact study in Bangladesh.
If successful, our work would define the contribution and mechanism of OSP-specific antibodies in affording
protection against a pathogen of global significance, define at the single cell and population level the intestinal
response during cholera, would allow us to define OSP-specific mucosal responses following cholera, and
would identify peripheral markers associated with such mucosa I OSP-specific responses. Our work would be of
high impact and would significantly advance the field by markedly improving our understanding of OSP-responses
during cholera. Our extension would build upon our significant progress-to-date.

Public health relevance
RELEVANCE (See instructions): Currently available oral cholera vaccines have a number of shortcomings. Developing improved vaccines or vaccination strategies is hampered by the reality that we do not currently understand the mechanism of immune protection against cholera although it is known that a primary component of that immunity targets O-specific polysaccharide (OSP) of V. cholerae. We here propose an investigative approach to define and evaluate OSP-specific responses during cholera.